Strengthening informed consent for authentic participation in perinatal HIV research

Project Summary
The field of maternal-infant HIV research has been especially attuned to the challenges of attaining authentic
informed consent in low-literacy populations affected by a condition that still carries social stigma. Our teams at
Columbia University Irving Medical Center (CUIMC), New York and Stellenbosch University, South Africa have
been undertaking research in maternal and child populations affected by HIV in South Africa over the past
several years. For three recent studies, we partnered with a local company to develop visual informed consent
forms (ICF) with the goal of strengthening the consent process. Yet we require additional data before entirely
replacing the standard written consent with the visual consent approach in future trials. Here we propose a
pragmatic evaluation of the current visual informed consent along with formative research. This data will
collectively inform a visual consent approach to be tested in a subsequent R01-level clinical trial. For this R21
study, we propose to partner with a social science expert in empirical ethics from RTI International to evaluate
one of the currently used visual ICFs in an NICHD-funded clinical trial (R01HD105492). The clinical trial is
testing the efficacy of a synbiotic supplement to reduce infant morbidity and improve growth in 210
breastfeeding mother-infant dyads, including mothers living with and without HIV. Dyads are recruited post-
delivery and consented before the infant is 4 weeks of age. The trial is underway in the Breede Valley, an
agricultural area in the Western Cape Province, South Africa. For Aim 1, we propose to prospectively evaluate
the visual ICF among 40 women living with HIV considering enrollment into our trial. We will randomize 40 new
potential participants to receive either the visual ICF at the initial informed consent visit (n=20) or to receive the
text only ICF (n=20). Data will be collected via mixed methods to explore knowledge and decision conflict or
regret immediately after the consent process and 8 weeks later. For Aim 2, a concurrent evaluation will be
conducted among 20 women living with HIV determined to be ineligible for the trial. Aim 2 will include concept
and usability testing of the visual ICF using a semi-structured, qualitative, think-aloud approach. Based on the
study data, the multidisciplinary study team will develop recommendations for the use of participant-centered,
low-literacy approaches to replace standard text-only ICFs in maternal-child health and HIV research
conducted with vulnerable populations. The outcome of this project will lead to our next study, where we will
develop and test a standalone visual consent form that is designed to replace a text only consent form in a
randomized trial. The long-term goal is to inform efforts to improve meaningful consent into studies and
contribute to greater inclusivity in clinical research.

Public health relevance
Public Health Relevance: Strengthening the informed consent process is an important step in attaining authentic participation in clinical research, particularly by the vulnerable populations affected by HIV. We will evaluate a visual informed consent document that uses pictures to aid in achieving better comprehension of the requirements of participation in research. The study is nested in an on-going trial in South Africa among mothers living with HIV and their infants.